Investigating multifactorial beta-catenin activation in hepatocellular cancers

Abstract
Hepatocellular carcinoma (HCC) is a deadly malignancy with limited treatment options, and lacks molecular-
targeted therapies. Activation of Wnt/β-catenin cascade has been shown to play a major role during HCC
pathogenesis. Mutations in CTNNB1, the gene encoding for β-catenin, interfere with its degradation leading to
its gain-of function (GOF) and activation, and are implicated in 20-35% of all HCCs. A mutually exclusive group
of additional around 8% of HCCs is the one with the loss-of-function (LOF) mutations in AXIN1, which encodes
for a scaffolding protein AXIN1, essential for β-catenin degradation. Our previous studies also showed that β-
catenin activation alone is insufficient for HCC development. Based on the concomitant presence of CTNNB1
mutations and c-MET activation in ~11% of human HCC, and the presence of LOF mutations in AXIN1 and c-
MET activation together in ~4% of human HCC, we established two murine HCC models, c-Met/β-catenin and
c-Met/sgAxin1, using sleeping beauty transposon/transposase and hydrodynamic tail vein injection (SB-HDTVI).
These models recapitulate the respective human HCC subsets based on gene expression studies. Intriguingly,
using these mouse models and human HCC samples, we discovered that AXIN1 LOF mutant HCC does not
show activation of canonical liver-specific β-catenin target genes such as glutamine synthetase (Gs) and Tbx3,
which was evident in CTNNB1-mutant HCCs. In contrast, Hippo cascade is inactivated in LOF mutations in
AXIN1 mutant, but not in CTNNB1-mutant HCCs. Based on the above observations, our overarching hypothesis
is that despite β-catenin being the common downstream effector, mutations in CTNNB1 and AXIN1 lead to
distinct molecular subtypes of HCC, and tumor development in these two classes requires participation of distinct
signaling pathways. We propose the following three specific aims to address our highly relevant hypothesis. In
Aim 1, we plan to define whether ligand dependent activation of Wnt/β-catenin is required for c-Met/sgAxin1
induced HCC formation in mice. In Aim 2, we will investigate Gs dependent and independent metabolic and
signaling cascades in mouse HCC development. And in Aim 3, we will characterize the functional contribution of
Hippo cascade in Ctnnb1 GOF and Axin1 LOF mutant HCCs. Altogether, our studies will elucidate the distinct
signaling pathways induced by β-catenin activation due to two distinct mechanisms, and how we may effectively
target these tumors based on genetic variations. The proposal represents an ongoing & productive collaboration
between Dr. Xin Chen from UCSF and Dr. Paul Monga from University of Pittsburgh. The results may pave a
way for precision medicine in HCC.

Public health relevance
Project Narrative Liver cancer is a deadly form of malignancy with limited treatment options. This project seeks to understand how different mutations in Wnt/β-Catenin pathway contribute to liver cancer development. The results will elucidate the distinct signaling pathways induced by β-catenin activation due to distinct mechanisms; and will pave a way for precision medicine for liver cancer treatment.